COBRE in Sensory Neuroscience

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. For two pilot projects aimed to improve the capability of non-linear optical microscopy (NLOM), which has increasing application in biology.